Targeting Cholinergic Deficits with Retinoic Acid after TBI

ABSTRACT
Cognitive deficits are a pervasive disability following traumatic brain injury (TBI). As of yet, there are no
treatments to combat these sequelae. Alterations in neurochemical (neurotransmission) and white matter
connectivity have been identified as two contributors to deficits in learning and memory behaviors after TBI. The
neurotransmitter acetylcholine (ACh) is a crucial factor in regulation of cognitive function, specifically in learning
and memory. Studies in experimental TBI have shown deficits in cholinergic function, and alterations in proteins
involved with cholinergic neurotransmission. Recent studies have found that exogenous all-trans retinoic acid
(ATRA), an active metabolite of vitamin A, can increase protein levels of choline acetyltransferase (ChAT), the
vesicle ACh transporter (VAChT), and acetylcholinesterase (AChE). This leads us to posit that ATRA can be
used as a potential therapeutic to improve cognitive behavior after experimental TBI. The primary goal of this
project is to provide proof-of-concept evidence that ATRA can attenuate cholinergic deficits after TBI. Moreover,
in support of this effect in the context of TBI, we provide preliminary data demonstrates that ATRA treatment can
attenuates spatial memory retention deficits after experimental TBI. Cholinergic deficits may also be, at least
partially, attributable to white matter damage. Neurons of the medial septum and the diagonal band of Broca
innervate the hippocampus via the fimbria–fornix bundle. In experimental studies, damage to the fimbra/fornix
produces cholinergic denervation in the hippocampus with concomitant deficits in cognition and ACh
neurotransmission. Clinically, diffusion MRI tractography studies have found decreased fimbria/fornix integrity
after TBI. Assessment of high-definition fiber tractography in preclinical TBI are well suited to understand global
connectivity and represent a high translational outcome to evaluate ATRA therapy. The primary hypothesis of
this project is to provide evidence that RA can attenuate cholinergic deficits after TBI. This hypothesis will be
tested in two Aims to elucidate the effects of ATRA on the ACh system and assess the effect of RA on the
integrity of axonal connectivity between cholinergic brain regions. Aim 1 will determine if ATRA treatment can
attenuate cholinergic the loss of key cholinergic proteins important for ACh neurotransmission (AChE, ChaT)
and (VAChT). To enhance the specificity of assessing ATRA’s effects on cholinergic function, a scopolamine
challenge paradigm will be utilized. Scopolamine, a muscarinic receptor antagonist, is a memory disturbing
agent. After experimental TBI, it has been reported that there is a reduction in the sensitivity of scopolamine to
disrupt memory. In Aim 2, the effects of experimental TBI on cholinergic-associated white matter tracts, both with
and without ATRA therapy, will be examined. If successful, this project will demonstrate for the first time the
therapeutic utility of RA to attenuate cholinergic protein and white matter deficits after TBI.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury alters the cholinergic systems which in turn may contribute to memory deficits. This project seeks to evaluate effects of a novel treatment using exogenous all‐trans retinoic acid, the active metabolite of Vitamin A, on proteins involved with the synthesis and release of acetylcholine after TBI. The project will also evaluate the effects of ATRA on the white matter fiber integrity of primary cholinergic pathways using DTI imaging.